NUTRITIONAL CARCINOGENESIS III--EFFECTS OF INDOLE-3-CARBINOL ON MARKERS OF COLO

The studies are designed to examine the effect of dietary alterations on colonic function histology and mRNA concentrations for regulatory proteins.